Core C: Structure Core

PROJECT SUMMARY - Core C: Structure Core
Structure-based vaccine antigen design is a key component of the prototype pathogen approach to pandemic
preparedness. For each prototype pathogen, vaccine developers must choose which viral protein(s) to include
in the vaccine as well as which form of the viral proteins to present to the immune system to elicit the optimal
immune response. Structural biology provides atomic-level information on viral glycoproteins, which is essential
for initiating the rational design of engineered vaccine antigens. Structural information is also crucial for
evaluating the engineered antigens, ensuring that the modifications and stabilizing substitutions produce the
intended effect. Additionally, structural biology plays a vital role in elucidating the epitopes and binding
mechanisms of monoclonal antibodies. This knowledge guides the design of antigens capable of binding to the
most promising antibodies, thereby eliciting an effective immune response. Antigen design, production,
characterization and structural biology will be performed in Core C: Structure as services to enable the Research
Projects to accomplish their objectives.
Core C will be led by Dr. Jason McLellan at the University of Texas at Austin, who is an expert in structural
virology and the development of structure-based interventions for viral pathogens. His laboratory has expertise
in the determination of viral protein structures and antibody complexes by X-ray crystallography and cryo-EM.
The McLellan laboratory also has extensive experience in protein engineering, expression, and purification. Dr.
Daisy Leung and her team will contribute to the biophysical characterization of antigens and antigen–antibody
complexes, and Dr. Anne Moscona and Dr. Tara Marcink will perform cryo-ET studies on whole virions to provide
structural information on higher-order glycoprotein assemblies and antibody interactions. One of the key services
provided by Core C is the rational and computational design of viral proteins to serve both as vaccine
antigens as well as bait for antibody isolation efforts. The second key service is the determination of structures
of viral glycoproteins, both alone and in complex with antibodies. These structures will provide the atomic-level
information required for structure-based antigen design, aid the characterization of antigen variants, define
antibody epitopes, and provide insights into mechanisms of antibody-mediated neutralization. As part of the
antigen design and development process, Core C will also express and purify viral proteins and variants
thereof. These proteins will also be rigorously assessed by Core C via biophysical methods, and those deemed
to be of sufficient quality and stability will be provided to the Research Projects and Cores to facilitate their
investigations. Collectively, the services provided by Core C will directly contribute to the development of vaccine
concepts, antigens, and antibodies that will inform development of medical countermeasures against
paramyxoviruses and bunyaviruses.